Viral vector technology for cell type specific gene delivery

Project Summary
This administrative supplement is to purchase a Sony benchtop SH800 cell sorter. Cell sorting is essential for
our approach to rationally engineer Adeno-Associated Virus tropism (see R01GM141152 ”Viral vector technology
for cell type specific gene delivery”). At the University of Minnesota Flow Core facility, cell sorting is only available
as a ‘fee-for-service’ performed by a flow core staff member. With this limitation, we have run into two issues: 1)
Because of heavy utilization of the Flow Core’s two sorters, we have trouble securing enough time to conduct
research outlined in our R01. 2) For many pilot/optimization experiments, the high throughput of the Flow Core’s
sorters is underutilized, and their complexity is actually a hindrance. A benchtop sorter will shorten the time
required for consecutive AAV design/measure/optimize cycles and thus enable an accelerated timeline of
experiment outlined in our R01. Taken together, the need to purchase a cell sorter dedicated to this project is
urgent.

Public health relevance
Project Narrative Viral vectors are an essential component for gene delivery in many therapies to treat inherited disorders and cancer but have practical limitations that warrant investments in rational engineering to enable precision gene therapy. We develop a novel viral vector platform technology that uses antibodies to target gene delivery to rationally identified cell types.